Probing the role of sensory regulation in sleep health and emotion dysregulation for autistic youth

PROJECT SUMMARY
Dr. Amy Hartman is a promising, early career occupational therapy scientist who is seeking training to facilitate
a smooth pathway towards an independent and impactful research career. Her long-term goal is to support
families with neurodivergent children (e.g., autism, ADHD) in areas of emotion dysregulation and sleep-wake
disturbances. As her research shifts to focus primarily on the unique experiences of autistic children and their
families, Dr. Hartman is seeking training from leading experts on (i) multimodal measurement of emotion
dysregulation, (ii) research methods for engaging a pediatric autistic population, and (iii) therapeutic experimental
methods and statistics. Dr. Hartman has built a multidisciplinary mentorship team to guide her training through
the K23 career development award period that leverages two cutting edge centers at the University of Pittsburgh:
the Autism Center of Excellence and the Center for Sleep and Circadian Science.
The proposed research study applies the training that Dr. Hartman has carefully crafted. In this study, Dr.
Hartman proposes to test a theoretical framework with 60 autistic children (ages 6-10) and their caregivers. This
framework examines the complex relationships between (i) bedtime emotion dysregulation, (ii) sleep onset
latency, and (iii) sensory over-responsivity, or sensory sensitivities- a common experience for autistic children.
Using a micro-longitudinal design with in-lab and at-home data collection, this study will produce rich data to
examine day-to-day and person-to-person variability on the constructs of interest. Additionally, Dr. Hartman has
developed a sensory-based bedtime manipulation protocol, called the Power Down, that targets sensory over-
responsivity as a hypothesized potential mechanism of action. The Power Down combines sensory integration
and mindfulness theories to decrease autonomic arousal through a gentle massage and mindfulness script.
Continuous ambulatory monitoring of electrodermal activity and actigraphy, coupled with daily caregiver reports
of emotion dysregulation and sleep, will provide preliminary measures of the impact of the Power Down on
bedtime challenges that are prevalent in autistic families.
Through this study, Dr. Hartman will expand the understanding of how the lives of autistic children and their
families are impacted by sensory over-responsivity and advance researchers' and clinicians' abilities to support
autistic children and their families with improved emotion dysregulation and sleep health. This K23 Career
Development award will provide the support Dr. Hartman requires to excel as an independent scientist.

Public health relevance
PROJECT NARRATIVE Emotion dysregulation and sleep disturbances are two common experiences for autistic children that exacerbate social difficulties and contribute to high rates of co-occurring psychiatric and behavioral problems, psychotropic medication prescription, and inpatient hospitalizations in this population. The proposed study will be the first step in examining the role of sensory over-responsivity in emotion dysregulation and sleep disturbances for autistic children. Through lab- and home-based data collection methods, this study has the potential to characterize day-to-day and person-level variability that can drive future intervention development.